Community-based Medication Adherence Support for Older Adults Living with HIV and Hypertension (CBA Intervention)

PROJECT SUMMARY
Due to the increasing availability of ART, people living with HIV (PLWH) are surviving longer and achieving life
expectancies similar to the general population. While this is a great achievement, noncommunicable diseases
such as cardiovascular disease (CVD) now account for a significant proportion of the morbidity and mortality in
PLWH. Poor HTN medication adherence is associated with uncontrolled blood pressure (BP) and increased
risk of CVD events such as myocardial infarction. Despite this risk, medication adherence research in PLWH is
primarily focused on ART with limited focus on adherence to other chronic comorbidities.
Medication adherence is a complex health behaviour that is driven by confluence of factors that operate at
micro- and macro-levels. As people age with HIV, their needs increase beyond solely managing HIV
medication adherence, to include management of other conditions and their medications. Increased pill burden
faced by older adults living with HIV (OALWH) with HTN, coupled with decline in cognitive function, cost of
transportation to the facility to get medication refill and lack of social support worsen adherence. Differences in
access particularly in LMICs, where ART is free and HTN medication are not, wider adverse effect profiles of
HTN drugs, and lack of polypills in HTN care could also contribute to non-adherence. Adherence support for
OALWH with HTN targeted at these factors may help improve medication adherence and reduce CVD events.
In this K43 application, the applicant proposes a training plan that will enable her gain skills and expertise in
human-centered design approach, implementation science theories, models and frameworks, and economic
evaluation of health interventions. Her research will addressing the following specific aims: Co-design a novel
CHV-led model for medication adherence support (CBA intervention) for OALWH using a human-centered
design approach (Aim 1); Conduct a pilot of CBA intervention and evaluate its feasibility (Aim2); and Conduct
costing and budget impact analysis of CBA intervention (Aim 3). The proposed K43 career development
activities including the outcome of the proposed research will culminate in my transition to an independent
researcher (R01-funded), contributing in the field of HIV and aging.

Public health relevance
PROJECT NARRATIVE OALWH with hypertension have an increased risk of cardiovascular morbidity and mortality due to suboptimal adherence to HTN medication. There is a critical need to develop interventions that promote patient- centeredness, improves HTN medication adherence and reduce CVD risks. This project will design, pilot and evaluate a community-based medication adherence support for OALWH with HTN.